DIET AND EXERCISE EFFECT ON PROTEIN METABOLIM

The effect of varying amounts of protein intake, with constant energy intake, on protein synthetic rates is assessed by means of stable isotopic tracers of amino acids.